Mechanisms of Volatile Anesthetic Modulation of Tandem Pore Potassium Channels

Volatile anesthetic (VA) agents produce rapidly inducible and reversible states of unconsciousness that are
vital for the delivery of general anesthesia, but also cause profound systemic hypotension, depressed
respiratory drive, and numerous other deleterious physiological perturbations that increase risks of morbidity or
mortality during surgery. Tandem pore (K2P) ion channels are VA responsive potassium leak channels that
are fundamental to basic human physiology and suspected mediators of some deleterious effects of VA’s. In
this K08 proposal, I will utilize my background in the field of ion channel physiology and biophysics to explore
the molecular mechanism by which VAs modulate K2P channels. In Aim1, I will define the molecular
determinants of VA binding to K2P channels, utilizing photoaffinity analogs of the haloether VAs isoflurane and
sevoflurane. I will identify VA binding sites in two VA sensitive K2P channels (TREK1 and TASK1) and
explore the molecular basis for the VA insensitivity of TRAAK K2P channels. Photolabeling results will be
verified for functional relevance by introducing mutations at identified anesthetic binding site residues and
performing functional studies to assess for altered gating behavior or anesthetic sensitivity. Molecular
dynamics simulation guided by photolabeling and functional studies will identify additional residues predicted to
contribute to VA binding. In Aim2, I will determine the mechanism by which VA binding alters K2P
conformation to effect gating. Single particle cryo-electron microscopy of TREK1 will be utilized to explore the
effects of VA’s on K2P conformational state and will produce the first structural characterization of the K2P C-
terminal domain known to regulate the modulatory effects of VAs and many other K2P modulators. By utilizing
a rapid mixing stopped flow fluorometric assay capable to resolving changes in the kinetics of K2P open pore
block by quaternary ammonium ions, I will examine the combinatorial effects of surrounding ionic composition,
lipid environment, VAs and other TREK1 modulators on the intracellular pore structure of TREK1, providing
functional context to our structural studies. By studying the biophysical basis for the interaction between K2P
channels and VA’s, I hope to lay the groundwork for a career translating studies of ion channel structure,
function and pharmacology into meaningful clinical interventions that improve the safety of anesthetic care. My
K08 research mentor, Dr. Crina Nimigean, is an international expert in the study of ion channel biophysics and
is extremely well suited to provide mentorship and guidance during the execution of this research project. The
study of ion channel pharmacology and biophysics as they pertain to mechanisms of anesthetic action has
been a historical focus of interest in the Weill Cornell Department of Anesthesia and both the departmental and
institutional environments provide an outstanding backdrop to enable successful completion of the proposed
studies, providing resources, protected research time, and an intellectually enriching environment with
numerous available advisors and potential collaborators.

Public health relevance
Tandem pore potassium ion channels are important target of volatile anesthetic agents. While these channels plays important roles in suppressing pain and preventing awareness during general anesthesia, they also regulate the physiology of the heart, airways, and smooth muscle, contributing to the dangerous side effects that often accompany the anesthetized state. This proposal aims to understand the regulation of tandem pore channels and to establish the molecular mechanism by which volatile anesthetics alter the activity tandem pore potassium channels, leading to insights that promise to improve the safety of general anesthesia.